Genetic Predisposition and Pharmacogenomics of HIV-Associated Cognitive Impairment

SUMMARY
With the introduction of potent antiretroviral therapy (ART), HIV is now manageable as a chronic disease, with
improved life expectancy of people with HIV (PWH). However, despite viral suppression, high rates of
comorbidities in PWH persist, due to a complex interplay between HIV, host genetics, inflammation, and
chronic viral infections. Understanding the role of genetic susceptibility to common diseases or drug responses
to ART could improve drug efficacy and reduce comorbidities. In our parent grant, we leveraged a large well-
characterized prospective cohort of PWH in care in the U.S (CNICS, Centers for AIDS Research Network of
Integrated Clinical Systems) with longitudinal clinical data to characterize the genetic landscape of a variety of
comorbidities and adverse side effects associated with ART, including liver disease, kidney disease,
atherosclerosis and osteonecrosis. However, in addition to these conditions, neurocognitive deficits also are a
pronounced consequence of HIV/AIDS. HIV-1 infection targets the central nervous system and leads to high
rates of delirium, depression, opportunistic central nervous system infections, and dementia. Long-term HIV
replication in the brain occurs in astrocytes and microglia, allowing the virus to hide from ART and later
compromise neuronal function. Cognitive impairment (CI) in PWH, culminating in Alzheimer's disease (AD), is
becoming an increasingly important issue as this population ages. HIV-associated mild to moderate CI affects
up to 50% PWH and results in lower quality of life, poorer adherence to medication, increased unemployment
and reduced life expectancy. The pathogenic mechanisms causing CI are often multifactorial, including
complex immunopathological processes controlled by HIV factors, the direct effects of ART, and genetic
predisposition. This supplement will leverage CNICS and the extensive data generated by the parent grant to
further understand genetic determinants of CI among PWH. We will use the digit symbol substitution
neurocognitive test (DSST), widely used to measure CI due to brevity, reliability, and consistent performance
across language, cultural and educational differences. We will: 1) Evaluate neurocognitive status in ethnically
diverse PWH and identify genetic determinants of CI. We will oversee the completion of the DSST from the
Brain Health Assessment, a computer-delivered, full cognitive assessment, in >1000 PWH with existing
genome-wide genotype data and evaluate the relationship between their neurocognitive status and a series of
polygenic risk scores for AD, dementias, and other cognitive traits. 2) Using systems pharmacology approach,
identify biological pathways and related key driver genes through which various ART regimens may promote
cognitive decline. We will treat neuronal cell lines with ART and search for the overlap between ART-induced
transcriptional responses and gene networks associated with AD and dementias. Variants in the key driver
genes will be evaluated in association with cognitive phenotypes in CNICS. This proposal is within the scope of
the parent grant and will help generate new valuable phenotype data to advance the field of AD and dementia.

Public health relevance
NARRATIVE Despite potent antiretroviral therapy (ART), cognitive impairment (CI) culminating in Alzheimer's disease, is becoming an increasingly important issue in people with HIV (PWH). We propose to extend our parent grant by evaluating neurocognitive status in an ethnically diverse prospective cohort of PWH and identifying genetic determinants of CI in the setting of HIV. We will also apply a systems pharmacology approach to detect biological pathways and key driver genes that promote ART-induced cognitive decline.